Pilot Studies

ABSTRACT
The Pilot Project Core will be managed by Lance Bauer, in consultation with the UCONN ARC Executive
Committee and the Program Advisory Committee. Both proposed and all new applications in the out years will
be reviewed to: (1) determine scientific merit; (2) improve the quality of the research through feedback,
revision, and mentorship (if needed); (3) create a system whereby resources are allocated fairly and equitably;
and (4) ensure that the research meets ethical standards.
The proposed Pilot Project Core has a heavy emphasis on supporting new investigators in alcohol research,
including new faculty members to our Medical School. Four pilot projects are proposed. The first project will
examine the ivergent effects of alcohol on metabolism of oxidative epithealial vs glycolytic mesenchymal breast
cancer cells, an important study given alcohol's putative role in increasing breast cancer risk. A second project
focuses on the use of cognitive remediation, a behavioral therapy, to reduce depression and drinking among
older adults. The third project is a one year follow-forward study of alcohol use and internet gaming among
young adults, an area of growing interest in the US. The fourth project is a study of parental alcoholism and
psychological adjustment in young adults. An open call will be issued in YR2 for pilot additional studies, funds
permitting.
The Pilot Project Core will allow investigators to pursue and develop innovative projects related to the etiology
and treatment of alcohol dependence and related behaviors, the theme of the Center. This component
provides an incubator for new ideas, provides for a critical and collegial review of proposals, and provides
resources to pilot test potentially important ideas. It is an especially important resource for new and junior
investigators.